Head-worn low intensity focused ultrasound (LIFU) device for enhancing sleep in substance use disorder (SUD)

Project Summary
While the addiction epidemic within the United States continues to grow, our ability to manage and treat addiction
as a complex, multifaceted disease remains limited. Individuals with Substance Use Disorder (SUD), including
Opioid Use Disorder (OUD), are particularly vulnerable to relapse not only because of the acute and severe
onset of withdrawal symptoms, but also chronic symptoms which can persist throughout the individuals’ lifetime.
Insomnia and sleep dysfunction represent the most severe and pervasive symptoms of both phases of
withdrawal and persist despite treatment. Sleep dysfunction experienced by individuals with OUD is exceptionally
anxiety-provoking and life-disrupting and is frequently a causative factor in a patient’s relapse.
Sleep dysfunction in OUD is characterized by not only a deficiency in the total amount of sleep, but also a marked
disruption of sleep architecture, with significant slow wave sleep (SWS) loss and fragmentation. In patients with
severe withdrawal, sleep may consist almost entirely of brief periods of rapid eye movement (REM), with little
SWS sleep, interrupted by numerous awakenings. Remedying insufficient sleep quality in OUD would likely
increase the probability of recovery by preventing relapse. Unfortunately, commonly prescribed sleep
medications have sedative and hypnotic effects with a risk of dependency too great for patients with OUD. New
non-pharmacological interventions to augment sleep are currently a critical unmet medical need.
Low intensity focused ultrasound (LIFU) has recently emerged as a potent tool for non-invasive stimulation or
suppression of intact brain circuits with great potential for treating a range of psychiatric disorders. Ultrasound
(US) beams can be focused onto specific deep regions of the brain without impacting surrounding tissue,
substantially reducing undesirable off-target effects present with medications or electrical and magnetic
stimulation. Unfortunately, the current technology used in LIFU research is limited to in-hospital use because of
formfactor and required real-time, clinician-guided MRI, and, therefore, does not readily translate to routine
addiction treatment.
Attune Neurosciences was founded to develop novel LIFU technologies capable of translating research findings
into a viable, non-invasive option to treat sleep and substance use disorders at home. In this Phase I SBIR, we
will reconfigure our existing head-worn LIFU device to reduce the form-factor of the front EEG components by
transitioning to a flexible circuit design and interchangeable front band that is more conformal to participants
foreheads (Aims 1 & 2). This will be followed by a 7-night form-factor and usability study with subjects recruited
from an outpatient addiction treatment facility and who are currently in recovery (Aim 3). Their input will be used
to inform the final design of our wearable headband-style device that can ultimately be used to treat multiple
aspects of addiction such as drug craving and underlying sleep disorders.

Public health relevance
Project Narrative Sleep issues are a primary cause of relapse in substance use disorder (SUD) patients. While there are numerous pharmacological strategies for enhancing sleep, the addictive nature of these compounds poses a significant threat to patients with addiction proclivity. Attune Neurosciences has developed an ergonomic wearable device for enhancing sleep through targeted low intensity focused ultrasound (LIFU) stimulation of the brain, and seeks to improve both device hardware and design for enhanced fit, comfort and data collection.